Application of Implementation Science approaches to assess the effectiveness of Task-shifted WHO-PEN to address cardio metabolic complications in people living with HIV in Zambia

TITLE: Administrative Supplement for “Application of implementation science approaches to assess the
effectiveness of task-shifted WHO PEN to address cardiometabolic complications in people living with
HIV in Zambia”
ABSTRACT
This project focuses on integrating the evidence-based WHO Package of Essential Noncommunicable Disease
Interventions (WHO-PEN) approach to managing cardiovascular disease risk factors and cardiometabolic
complications of HIV into routine care settings for persons living with HIV in Lusaka, Zambia. During the formative
UG3 phase of the project, we successfully adapted WHO-PEN for the national HIV program in Zambia using
local data and implementation science theory and created a multi-component, evidence-based intervention that
we have coined “TASKPEN”. TASKPEN addresses challenges faced by HIV patients who have cardiometabolic
comorbidities or complications related to HIV or its treatment, and aims to improve detection and management
of cardiometabolic non-communicable diseases (NCDs) that disproportionately affect people living with HIV in
Zambia. TASKPEN evidence-based components include: a “one-stop shop” for HIV and cardiometabolic disease
care; guidelines, training materials, and treatment algorithms for health workers based on WHO PEN; laboratory
services for screening and diagnostic testing of cardiometabolic NCDs; and a strengthened NCD medication
supply chain. TASKPEN delivers these components by employing an overarching implementation strategy of
clinical service integration and sub-component strategies of task-shifting, practice facilitation, and changing of
physical infrastructure and equipment to accommodate screening and treatment of hypertension, diabetes
mellitus, and dyslipidemia. Our overarching and sub-component strategies will enable nurses and community
health workers to deliver integrated, evidence-based care for these conditions in routine HIV clinical settings with
support provided by practice facilitators and NCD decision support tools imbedded in the national electronic
medical record. As the individual components of TASKPEN are already recommended by Zambia national
guidelines, the TASKPEN package will be delivered under the auspices of routine HIV care. We hypothesize
that TASKPEN will result in dual control of both HIV and cardiometabolic NCDs of interest, and improve
secondary clinical endpoints, including cardiovascular disease risk (as determined by the Atherosclerotic
Cardiovascular Disease, ASCVD, risk score) and HIV viral suppression for persons living with HIV attending 12
HIV clinics serving as our study sites in Lusaka, Zambia. To test this hypothesis, we plan to conduct a type 2-
hybrid effectiveness-implementation stepped-wedge trial, which is a quasi-experimental design that allows for
measurement of clinical effectiveness alongside assessment of implementation outcomes and strategies. The
trial incorporates several clinical and methodological innovations, including the first use of point-of-care
diagnostics for NCDs in Zambia, a total clinic sampling approach to make generalizable insights into the impact
of TASKPEN on the entire HIV care population, and cost-effectiveness modeling. In addition, the trial serves as
a hands-on training platform for five pre-doctoral, doctoral, and post-doctoral implementation science fellows
from the University of Zambia, including a recipient of a small research program grant from NHLBI. The funding
requested via this supplement will support strategic investment in the following areas critical to UH3 success and
where unexpected expenses were incurred: 1) putting in place basic health system building blocks required for
TASKPEN introduction; 2) ensuring quality data collection by retaining existing, trained study staff; and 3)
sustaining funding for five pre/post/doctoral fellows mentored through the project. Our hope is that by the end of
the project, the Ministry of Health will consider wider scale-up of the TASKPEN intervention in the Zambian health
system, and that our fellows will be well-positioned to apply for independent NIH D43 or K43 funding.

Public health relevance
PROJECT NARRATIVE This study aims to apply empirically supported implementation science strategies, including task shifting, audit and feedback, and eHealth clinical decision support to integrate management of cardiovascular disease risk factors and cardiometabolic complications of HIV within a robust HIV service delivery platform in Lusaka, Zambia. We will use established implementation science theories, strategies, and constructs to implement an adapted version of the evidence-based WHO Package of essential noncommunicable disease interventions (WHO PEN) using non-physician health workers, and rigorously evaluate the intervention using a pragmatic, stepped-wedged trial design.